Insomnia Treatment and Cardiometabolic Health in Older Adults with Posttraumatic Stress Disorder

Project Summary/Abstract
Monica Kelly, PhD is an Adjunct Assistant Professor at the David Geffen School of Medicine at UCLA. She is
fully committed to becoming an independently funded investigator specializing in the study and treatment of
sleep, cardiometabolic health and posttraumatic stress disorder (PTSD) in older adults. Dr. Kelly is an ideal
candidate for this field of research with over 10 years of sleep and PTSD research experience, advanced
geriatrics fellowship training, and licensure in clinical psychology. This K23 award will provide foundational
career development skills for achieving her long-term goal of understanding and improving mental and physical
health outcomes for older adults with insomnia and PTSD. Data collected will provide the basis of a larger,
randomized controlled trial designed to examine the most effective treatment sequencing for mental health and
cardiometabolic disease risk outcomes among older adults with comorbid insomnia disorder and PTSD.
Career Development and Training Plan: The proposed work will be carried out at the UCLA and take
advantage of available resources within the VAGLAHS, providing a rich training environment and the ability to
conduct the proposed research and training plans. Dr. Kelly's team of nationally renowned mentors include
Drs. Jennifer Martin (primary mentor; behavioral sleep interventions expert; K24 awardee), Cathy Alessi
(geriatric sleep and health expert), Peter Liu (cardiometabolic health and sleep expert; K24 awardee), and
Thomas Neylan (PTSD and sleep expert). Available resources include UCLA's Clinical and Translational
Science Institute (CTSI), Multicampus Program in Geriatric Medicine and Gerontology (MPGMG), and the
Geriatric Research, Education and Clinical Center (GRECC). Her training plan features carefully curated
didactic and experiential training aligning her research and training goals in 1) clinical trials, 2) cardiometabolic
health, 3) circadian rhythms, and 4) career skills necessary to become an independent clinical investigator.
Research Plan: The proposed pilot randomized controlled trial will address a gap in knowledge related to
addressing modifiable risk factors for cardiometabolic disease through treating residual insomnia in the context
of PTSD in older adults. This project utilizes evidence-based interventions and standard clinical care
measures. The study will evaluate the benefits of 5 sessions of Cognitive Behavioral Therapy for Insomnia
(CBT-I) versus control, following 12 sessions of Cognitive Processing Therapy (CPT) for PTSD in older
Veterans, an expanding group of individuals at elevated risk for PTSD, insomnia and cardiometabolic disease
morbidity and mortality. The aims of this project are to 1) Evaluate the added benefits of CBT-I versus control
on sleep, PTSD, and cardiometabolic risk biomarkers; 2) Evaluate CBT-I versus control following CPT on
cardiometabolic risk biomarkers and quality of life; and 3) Evaluate the durability of the sleep, cardiometabolic
and quality of life benefits of CBT-I following CPT versus control following CPT at 6-month follow-up.

Public health relevance
Project Narrative Both insomnia and Post Traumatic Stress Disorder (PTSD) are independent risk factors for cardiometabolic diseases; the leading causes of morbidity and mortality in the US for which the growing geriatric population is at elevated risk. PTSD and insomnia disorder frequently co-occur yet require unique treatments, thus the proposed project will evaluate the added benefits of treating residual insomnia symptoms with Cognitive- Behavioral Therapy for Insomnia (CBT-I) following Cognitive Processing Therapy (CPT) for PTSD among understudied older adults with PTSD. Findings from this pilot study will expand our understanding of the relationships between evidence-based insomnia and PTSD treatments and key outcomes of sleep, PTSD symptoms, cardiometabolic health and quality of life in older adults with PTSD and insomnia while informing future research.